Experience-Dependent Plasticity in Superior Colliculus and Natural Visual Behavior

PROJECT SUMMARY/ABSTRACT
Our long term goal is to identify and understand the mechanisms underlying plasticity in visual
stimulus detection and visually-guided pursuit. Plasticity in these visuospatial orienting behaviors
are perturbed in both neurodevelopmental disorders such as autism as well as neurological
disorders resulting from traumatic experiences such as PTSD. Thus, development and plasticity
of these visual orienting behaviors critically impact healthy visual processing. In order to
ultimately develop targeted therapies that alleviate the specific visual processing deficits
associated with each disorder, it is necessary to first understand the mechanisms that underlie
the development and plasticity of visual stimulus detection and pursuit behaviors more
fundamentally. We will start to address this critical gap by investigating the development and
sensory experience-dependent plasticity of function of specific cell types of the superior colliculus
in the mouse as they relate to specific changes in visual stimulus detection and pursuit behavior.
The superior colliculus is a key subcortical visual system that processes salient environmental
stimuli, receives substantial input from cortex and mediates rapid spatial orienting behavior in all
mammals. The function of cells in this structure are sensitive to visual experience and change
significantly over development, and, two classes of cells in the superior colliculus known as the
wide- and narrow-field vertical neurons specifically underlie visual stimulus detection and pursuit.
However, we do not understand how these precise neural circuits are directly impacted by visual
experience throughout life. The mouse affords access to a broad range of sophisticatedgenetic
tools that may be used to close this gap in our understanding. In AIM 1, we will quantify stimulus
detection and pursuit behaviors at key developmental stages from postnatal day 21 to adulthood
to understand how these visual orienting behaviors change in the mouse. In AIM 2, we will
determine whether specific circuit changes support developmental changes in behavior by quantifying
the neural encoding of visual stimuli specifically in the wide- and narrow-field cell circuits of the
superior colliculus in the behaving animal. We will measure specific neural activity using high-
density in vivo electrophysiology, optogenetics, virus mediated circuit tracing, calcium imaging
and functional ultrasound imaging. In AIM 3, we will study the experience-dependent
development of both behavior and specific circuit function in the superior colliculus by
manipulating visual experience by allowing mice to hunt live insects (enrichment). Overall, this
work will advance our understanding of the neural circuit mechanisms underlying successful
spatial orienting behaviors that are essential for visual perception.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): HOY, JENNIFER, LYN PROJECT NARRATIVE This work will identify neural circuit mechanisms underlying the development of visual stimulus detection and pursuit behavior. Appropriately orienting towards salient stimuli and filtering out distraction is required for healthy visual cognition and attention in adults and is sensitive to developmental experience. Autism, schizophrenia, ADHD and generalized anxiety are disorders rooted in perturbed development and are associated with deficits in the ability to properly modulate visuospatial orienting behavior.